Promoting positive parenting for mothers with OUD: Implementation of a video-coaching intervention in pediatrics

PROJECT SUMMARY/ABSTRACT
The US opioid epidemic is a public health emergency with devastating intergenerational impacts. Children with
in-utero exposure to opioids are at high risk for emotional and behavioral difficulties as well as increased risk of
substance misuse in adolescence and adulthood. Parenting behaviors represent a modifiable factor in this risk
pathway. Maternal opioid use disorder (OUD) increases risk for maladaptive parenting behaviors associated
with long-term child behavioral and mental health problems. There is increasing evidence that parenting
interventions for mothers with OUD improve parenting behaviors and reduce child behavior problems.
Research has also shown benefits of parenting interventions for maternal psychosocial functioning, including
reduction of relapse risk. Despite promise, existing parenting interventions for mothers with OUD have been
limited in terms of accessibility and uptake. There is an urgent need to make empirically supported preventive
parenting interventions acceptable and readily available to support dyads affected by OUD, especially during
the preschool period when behavior problems linked to poor adult mental health often first manifest. A parent-
child interaction therapy-based prevention model entitled THRIVE offers a brief, accessible video coaching
strategy to promote responsive parenting for mothers with OUD. THRIVE is a uniquely promising approach to
meet the needs of mothers with OUD because THRIVE includes emotion coaching, which has been shown to
improve caregiver emotion regulation, a critical intervention target for mothers with OUD. Integration of
THRIVE into pediatric primary care is a promising, scalable model for engaging mothers in a non-stigmatizing
setting and increasing access through use of telehealth. The goals of this K23 are therefore to test the
effectiveness of this intervention among mothers with OUD and their preschool children and to tailor
implementation for this population in the pediatric primary care setting. Aim 1 will use quantitative and
qualitative methods to identify facilitators and barriers to implementation in this new context for this population,
guided by the Consolidated Framework for Implementation Research. Aim 2 will engage primary care staff and
mothers with OUD in implementation blueprinting - a participatory process to address identified implementation
barriers and build a tailored implementation package. Aim 3 will be a pilot trial to test both implementation and
effectiveness outcomes. To achieve the proposed goals, I require training in evidence-based maternal
substance use disorder treatment, implementation blueprinting, and design and conduct of clinical prevention
trials. I will acquire these skills and conduct the proposed research at Boston Medical Center, the largest safety
net hospital in New England and national leader in the care of individuals with OUD. At the end of the K23
award period, I will be well-positioned to accomplish my long-term goal to become an independent investigator
with expertise in testing and implementing parenting interventions to prevent negative outcomes for mothers
with OUD and their children.

Public health relevance
PROJECT NARRATIVE Parenting interventions that promote responsive caregiving among mothers with opioid use disorder have the potential to both support mothers in their recovery by helping them cope with caregiving challenges and also promote the optimal socioemotional development of their children. This proposal will test the effectiveness of a brief, video coaching intervention among mothers with opioid use disorder and tailor implementation of the intervention for this population in the pediatric primary care setting. This research will inform scalable approaches for making parenting interventions acceptable and readily available through pediatric primary care to support dyads affected by opioid use disorder.